Regulation of pancreatic islet cell fate

Project Summary/Abstract
Significant research efforts are currently underway to understand and prevent the pathogeneses of Type
1 and Type 2 diabetes, both of which are associated with the gradual loss of functional insulin-producing b cells.
Progress has been made with using human pluripotent stem cell (hPSC) populations as alternative sources of
islet cells; however, the efficient production of pure populations of fully functional b cells has not yet been
achieved. Furthermore, the current protocols result in highly variable differentiations depending on the stem cell
source, differentiation procedure and user. In addition, both endogenous and stem cell-derived islet cells display
inherent phenotypic instability and often undergo spontaneous dedifferentiation and/or reprogramming in
pathophysiological conditions, which results in the loss of cellular identity and phenotypic dysfunction. These
challenges suggest that there is still a great need to identify the precise transcriptional and epigenetic
mechanisms that promote the specification and maintenance of islet cell identities.
We and others have demonstrated that development and maintenance of b cell identity requires the
continuous activity of several non-redundant transcriptional programs. Although many of the transcription factors
that are essential for maintaining a and b cell phenotypes have been characterized, we lack a complete
understanding of how cell-specific gene programs are regulated to specify and maintain these closely related
cell lineages in mice, and there are varying reports related to their respective roles in human pancreas
development. This proposal will allow us to gain a more complete understanding of the basic molecular
mechanisms underlying islet cell differentiation and the maintenance of islet cell identity/function; this knowledge
will pave the way to improved human islet cell differentiation protocols and the identification of better treatments
for islet cell dysfunctions in diabetes. These studies are facilitated by increased access to novel and improved
molecular technologies. Furthermore, our studies in rodent models are providing important biological and
physiological context that will be directly translated into the hPSC differentiation system. Our first aim will
characterize the differential molecular mechanisms that regulate a vs b cell programs in mice. We will focus on
the combined molecular activities of NKX2.2, NKX6.1, KLF4 and CHD4 in regulating endocrine cell fate
decisions. We will also take an unbiased approach using combined single cell ATAC-Seq and RNA-Seq to
characterize the transcriptional landscape associated with islet cell fate decisions in vivo. The second aim will
characterize the role of the chromatin modifier protein CHD4 in regulating b cell development and function, and
in modulating NKX2.2 and NKX6.1 regulatory activities. The third aim will begin to apply this knowledge to the
directed differentiation of human islet cells from hPSCs. We propose to identify the necessary and sufficient
functions of NKX2.2 and NKX6.1 in regulating a and b cell fate decisions. We will also use this platform to identify
the chromatin and gene expression landscapes regulated by NKX2.2 and NKX6.1 during these lineage choices.

Public health relevance
Project Narrative Significant research efforts are currently underway to understand and prevent the pathogeneses of Type 1 and Type 2 diabetes, both of which are associated with the gradual loss of functional insulin-producing b cells. Progress has been made with using human pluripotent stem cell (hPSC) populations as alternative sources of islet cells; however, the efficient production of pure populations of fully functional b cells has not yet been achieved. This project will use mouse and hPSC models to identify the complex transcriptional and epigenetic mechanisms that promote the specification and maintenance of islet cell identities.